Wireless and Noise Attenuating Headset for Automated Hearing Screening

DESCRIPTION (provided by applicant): Hearing loss is a leading public health concern, with about 17% of American adults reporting some degree of impairment. Of those, fewer than 20% seek help for their condition for a variety of reasons. To address this issue, the National Institue of Deafness and Other Communication Disorders (NIDCD) is seeking solutions to improve hearing healthcare access and lower its cost (see RFA-DC-12-004). Solutions requested include enabling currently available commodities (telephone, Internet, and smartphones) to conduct surveillance of hearing loss, Internet screening systems, and automated audiometry to be used beyond traditional clinical and research environments. One key challenge to implementing these solutions is the need to generate calibrated tones and to ensure a low noise environment. Creare proposes to complete development of a hearing threshold screening device that performs automated audiometry and is controlled through a mobile platform. Our device is designed for use at point-of- care (POC) locations with very limited personnel and testing facility resources; it can also be used for self-assessment. Background noise attenuation is provided with innovative, integrated high quality noise attenuating ear cups. The resulting device will provide a solution to the problem of hearing healthcare access by allowing quality screening at POC locations, in community centers, pharmacies, and big box stores (which are now making low-cost hearing aids available). In addition, because it is designed for use with mobile platforms and is calibrated to applicable standards, the proposed device will enhance the development of quality audiology applications for use with smartphones, tablets, and the Internet. During Phase I, we demonstrated the feasibility of our innovation by building a benchtop prototype of the device and testing its performance using standard audiometry. We showed that thresholds measured with our prototype were equivalent to thresholds measured with a commercial audiometer on a pilot human study that included 16 subjects. During Phase II, we will refine the design of our device, build several integrated prototypes, and demonstrate their use and performance with several human subject studies in target locations and populations. The Phase II human study will have two objectives: (1) compare the test results and test/retest variability using the new device to what can be achieved with existing devices, and (2) compare the performance of our device in a representative noisy environment such as POC locations to its performance in a quiet sound booth. The Creare team is extremely well qualified to successfully develop and commercialize this hearing screening device for automated and remote applications. Our system is made possible by leveraging hardware and software that Creare has previously developed for hearing assessment in varied settings including remote assessment in developing countries, Otoacoustic Emission (OAE) measurement in noisy environments, and advanced hearing protection.

Public health relevance
PUBLIC HEALTH RELEVANCE: Hearing loss is a leading public health concern, with about 17% of American adults reporting some degree of hearing loss, yet fewer than 20% of them seek help for their condition. During the proposed effort, we will develop innovative technology that will enable new hearing assessment paradigms to reach underserved communities, expand hearing screening to a wide array of accessible locations, and lower the cost of hearing tests.